AFC-HWWT

AFC HWWT Project Summary
AFC has established networks for delivering high quality training to emergency responders in the
southeastern United States and to Native American tribes throughout the country. The proposed training
project would take vital training to communities with public safety agencies on tight budgets. This program has
developed the capability to deliver all levels of hazardous materials response training (Awareness, Operations,
Technician, and Incident Commander) on-site at the response agency to eliminate the expense of sending the
trainees out to central training sites. AFC also delivers specialized courses in areas of Incident Command
System, Air Monitoring, Confined Space Rescue. AFC staff have built innovative portable training props and
accumulated enough equipment to conduct courses with a majority of time spent in realistic hands-on activities
with actual, functional equipment. The AFC campus boasts impressive resources of props and equipment to
support realistic large-scale exercises in hazmat response and in confined space rescue. Whether at home or
on the road, AFC instructors strive for realistic and effective training for the trainees.
In nearly twenty-five years working with Native American communities, AFC has gained a reputation for
providing exciting and appropriate training to any tribe, even in small and remote locations. These tribes often
have responsibility for large areas of tribal lands and do not have large populations and resources. By
partnering with Native American Fish and Wildlife Society, AFC will reach out to the tribes to offer progressive
levels of training to the tribal response teams. In this proposal, AFC also offers hazardous waste worker
training for tribal environmental personnel in addition to the emergency response courses offered. This is
important for protecting people who assess, sample, and remediate contaminated environments.
With Hazardous Waste Worker Training (HWWT) Program funds, AFC proposes to train over 1,600
Native American responders throughout the country and over 2,100 public safety responders in the southeast
US in a total of 195 courses and 75,400 contact hours. Additionally, AFC will support secondary training
conducted separately by trainees at their home tribes or agencies that will reach an additional 1,500 trainees in
100 classes for 24,000 contact hours. Total training with this component in the five-year grant is projected to be
295 classes for 5,200 trainees and 99,400 contact hours.

Public health relevance
Component Project Summary Not Required